Development of iPSC-derived iNKT cells to promote hematopoietic engraftment

Summary
Hematopoietic stem cell transplantation (HSCT) is a potentially curative treatment for a variety of malignancies
and other hematological disorders, and also holds promise for treatment of infectious diseases such as HIV.
However, HSCT is limited by high risks of morbidity and mortality from complications such as graft failure
(which leads to high susceptibility to lethal infections) and leukemic relapse. New strategies to improve
outcomes of hematopoietic transplantation would thus have a significant clinical impact. This project focuses
on developing invariant Natural Killer T (iNKT) cells derived from human induced pluripotent stem cells (iPSCs)
as an adjunct HSCT cellular therapy designed to promote successful hematopoietic engraftment. In recently
published preliminary studies, we showed that addition of allogeneic human CD4+ iNKT cells to human
umbilical cord blood transplants led to dramatically improved hematopoietic engraftment in immunodeficient
mice. The engraftment-promoting activity of iNKT cells was due to their interactions with cord blood
monocytes that resulted in production of several potently pro-hematopoietic factors, including the cytokines
GM-CSF and IL-3 (produced by iNKT cells), and PGE2 (produced by monocytes in response to signals from
iNKT cells). Prior studies in murine models have established that cytokine programs and functional properties
of iNKT cells are controlled by two key transcription factors, PLZF and E4BP4. How these transcription factors
influence the cytokine profiles of human iNKT cells remains unclear, and specifically, their impact on iNKT cell
production of GM-CSF and IL-3 and interactions with monocytes is not known. Aim 1 of this project proposes
to generate human iPSC-derived iNKT cells lacking or over-expressing PLZF or E4BP4. Aim 2 will determine
the impact of these transcription factors on the ability of iPSC-derived iNKT cells to promote human
hematopoietic engraftment and on graft-versus-lymphoma (GVL) activity. Through these studies we will gain
highly novel insight into the impact of PLZF and E4BP4 expression on iNKT functional properties, and we will
establish the feasibility of generating iPSC-derived iNKT cells with modified transcription factor expression
designed to stabilize specific functional programs. This will lay a foundation for designing iPSC-derived iNKT
cells that are transcriptionally tuned to promote hematopoietic engraftment without adversely affecting GVL.

Public health relevance
Narrative Bone marrow transplantation is a procedure that is done to treat a variety of cancers as well as certain genetic diseases of the immune system. While this procedure has the potential to cure these serious conditions, the steps needed to prepare a patient’s body for transplantation (called “conditioning”) are difficult to tolerate. Additionally, if the transplanted bone marrow cells fail to thrive the patient will be left highly vulnerable to disease. This project will investigate a new therapy that is aimed at reducing the need for harsh conditioning steps and that will help transplanted bone marrow to take hold and grow.